Scientific Information Management and Literature-Based Evaluations for the DTT - Support for Report Preparation

A number of complex scientific reports are prepared under this project by compiling information from DTT staff, contract laboratory reports, and DTT data tables. Information is compiled, reviewed for internal and external consistency, and for scientific accuracy. Reports prepared under this project included Technical Reports on TCPP, black cohosh, and triclosan, Toxicity Reports on soluble vanadium compounds, NIEHS reports on aromatic phosphate flame retardants and per- and polyfluoroalkyl substances (PFAS).

Keywords: peer review